New radiotracer development to study immune cell mobilization of granzyme proteolytic activity

Project Abstract:
The human granzymes are a somewhat mystical class of five serine proteases (A, B, H, K, M) that are expressed
and conditionally secreted by select lymphocytes like natural killer (NK) and cytotoxic T cells (CTL). Based
largely on data for A and B, granzymes have been historically regarded as pro-apoptotic effectors whereby they
are presented transiently by NK and CTLs at the immunological synapse with a problematic target cell (e.g.
cancer cell, pathogen infected cell), and immediately shuttled into the cytosol via perforin to initiate cell death.
However, emerging data has begun to challenge this canon and present a more complex model in which
secreted granzymes perform essential signaling functions in extracellular space, including activation of
macrophages as part of host defense. Interestingly, dysregulation of granzyme presentation and/or proteolytic
activity may also underlie the pathobiology of debilitating diseases like neurodegenerative or systemic
autoimmune diseases. Thus, more fully elaborating the biology of granzymes is an important unmet need, and
requires technologies to study granzymes in the most clinically relevant animal models and humans themselves.
To this end, we developed a novel imaging approach we term “restricted interaction peptides” (RIP) to detect
granzyme proteolytic activity in vivo with PET. Mechanistically, RIPs are administered as an inactive pro-form,
whereupon internal cleavage of the RIP by the target endoprotease releases a radiolabeled peptide that
immediately associates with nearby phospholipid membranes (i.e. the plasma membrane of the target cell).
Thus, accumulation of the radiolabeled cleavage product adjacent to the endoprotease provides a readout of the
relative units of enzyme activity within a region of interest. As preliminary data, we developed 64Cu-GB1, a RIP
that measures granzyme B activity on PET. Our proof of concept data show that 64Cu-GB1 detects the cytotoxic
pool of granzyme B activity trafficking to pathogenic target cells, but also an unexpected non-cytotoxic pool
elicited as part of an inflammatory response to an endotoxin. During this project, we will expand upon these
data in several important directions. First, we will test in Aim 1 if 64Cu-GB1 can be applied to study granzyme B
proteolytic activity in the spontaneous immune responses arising due to pathogen stimulation. These data will
be crucial to understanding the utility of this methodology beyond simply detecting pharmacologically augmented
anticancer immune responses. During Aim 2, we will expand the RIP toolkit to develop and study probes
targeting the tryptase proteolytic activities of granzymes A and K. During the final Aim, we will carry out the late
stage preclinical experiments required to judge the feasibility of human imaging with RIP probes. As a model
system, we will study our lead candidate 64Cu-GB1. If successful, this project will confer new translational
technologies at a crucial inflection point away from the classical view as simply pro-apoptotic effectors toward
multifaceted regulators of human immunology and host defense against pathogens.

Public health relevance
Project Narrative: The overall goal of this project is to develop first in class radiotracers to study in vivo how immune cells mobilize granzymes to combat deadly pathogens. This project will span new probe development and application to clinically relevant animal models of viral or bacterial infections and conclude with late stage preclinical studies to establish the long term feasibility of human imaging for this novel probe class. If successful, this project will confer new translational tools to begin probing the emerging non-cytotoxic functions in host defense for this enigmatic enzyme class.